Influence of ligand on specification of gamma/delta fate and function

The goal of this proposal is to understand the molecular processes controlling γδ lineage commitment and specification of effector fate. Both events occur during development in the thymus; however, our understanding of the developmental cues controlling these fate decisions remains incomplete. Accumulating evidence suggests that both γδ lineage commitment and effector fate are influenced by differences in T cell receptor (TCR) signal strength. The differences in TCR signal strength influence fate by inducing Id3, an antagonist of E protein DNA binding. While E proteins clearly play a central role, their influence on developmental outcomes is almost certainly modulated by additional transcription factors and the extracellular signals that control their expression and function. Accordingly, these fate decisions are too complex to be understood by focusing on one gene or pathway and so require the comprehensive, network-based approach pioneered by Murre. We will employ this approach to elucidate the E protein targets that are crucial for these fate decisions, as well as, the DNA-binding proteins and signaling cascades with which they cooperate. In doing so, we will exploit the γ δTCR transgenic (Tg) model, KN6, whose known selecting ligand, the non-classical MHC-I molecule T10d, can be manipulated to alter TCR signaling. In Aiml, we will employ KN6 Tg mice, and endogenous T10/22 reactive γδ progenitors, to determine how specific ablation of the T10/22 ligand affects γδ lineage commitment, repertoire selection, and effector function. Aim2 will exploit the network approach described above to determine how IdS is able to promote development of Vγ2+ and Vγ3+ γδ T cells, but restrains the development of Vγ1.1+ innate γδ T cells. Aim3 will exploit our novel marker of γδ lineage commitment, CD73, to determine whether γδ lineage commitment and specification of effector fate are separable or occur simultaneously. The molecular processes defining lineage commitment will be elucidated through the comprehensive network being assembled in Project 4, and by genetic tests of the resulting molecular model. These efforts require the capabilities of all program members and promise to reveal critical new insights into how γδ T cell development is controlled.

Public health relevance
γδ T cells regulate inflammation, preserve epithelial barriers, and are particularly adept at killing cutaneous tumors. Accordingly, understanding the molecular processes controlling their development and function may enable their manipulation for therapeutic benefit. Moreover, our investigation of molecular effectors controlling T lineage commitment is also of fundamental importance for other developmental processes, since control of cell growth and differentiation is a recurring theme in development and transformation.